CORE--RESEARCH ENHANCEMENT AND ADMINISTRATION

The long term objective of this activity is to enhance faculty and research associates capability and understanding of funding and grantsmanship. The specific aims of this activity include: identification of funding opportunities; administrative oversight of the development of faculty research programs; one-stop proposal preparation support; professional growth of research enhancement staff; administrative and secretarial support for the RCMI activities; provisions of technical support for maintenance of analytical equipment; and provisions of technical support for the establishment of local area network.